MT INBRE: A Multidisciplinary Research Network

MT INBRE IV has two overarching goals: 1) maintain and further develop the Montana
research network and student pipeline, and 2) utilize this network to address the serious health
disparities Montana's rural and Native communities face. MT INBRE IV will support and mentor
investigators from research universities, primarily undergraduate institutions (PUIs), and tribal
colleges (TCs) through leading edge biomedical science and best practices in Community
Based Participatory Research (CBPR) to address health disparities in Montana's rural and tribal
communities. We believe that Montana communities can drive research and contribute to
finding solutions to mitigate the health disparities they experience.
Because of the severity and pervasiveness of health disparities in our state, this emphasis
will continue in MT INBRE IV, but within that focus, we will add new research areas that have
emerged from MT INBRE III, including resiliency, mental health and suicide prevention,
nutrition, food security/sovereignty, and metabolic diseases. By adding food
security/sovereignty and nutrition to our research focus, MT INBRE IV will help to develop a
holistic health approach that goes beyond treatments and drugs that alleviate symptoms.
Rather, our targets will be the mechanisms of resiliency, improved mental health, and suicide
prevention. These efforts will be accomplished by instituting innovative partnerships with
programs and institutions in Montana and the Western IDeA Regional Network to maximize
resources, collaborations, and opportunities available to Montana's researchers and students.
MT INBRE IV will realize goals and research targets through four specific aims.
Aim 1: Strengthen Montana's biomedical and bioinformatics infrastructure through continued
development of shared facilities, research collaborations, focused working groups, and training
opportunities. Aim 2: Build and increase the state's research base and capacity by providing
support to faculty, postdoctoral fellows and graduate students at participating institutions. Aim 3:
Provide research opportunities for students from primarily undergraduate institutions,
community colleges, and minority institutions and serve as a pipeline for these students to
continue in health research careers within IDeA states. Aim 4: Share established programs and
infrastructure through a tristate Regional Alliance of INBRE Networks (RAIN) with Idaho,
Montana and New Mexico to reduce redundancy, increase interdisciplinary research
collaborations among faculty, and broaden research and education opportunities for students.

Public health relevance
Rural communities in Montana, particularly Native American communities, experience severe health disparities. MT INBRE IV builds the capacity of the statewide research network to address these disparities through collaborations with the state's rural and tribal populations.